Chaperone Actions in CFTR Biogenesis

Abstract
CFTR’s complex folding scheme leads to near-complete ER-associated degradation (ERAD) of the
common CF disease mutant, F508del CFTR, and of a significant fraction of the WT protein. Defects in protein
folding and aggregation underlie a diverse set of ~100 diseases, and their treatment requires an understanding
of the checkpoints that determine protein fate. We previously identified novel physical and functional
interactions of CFTR with the small heat shock protein (sHsp), Hsp27, which led to mutant CFTR conjugation
with the small ubiquitin-like modifier, SUMO. F508del CFTR was selectively degraded by this Hsp27/SUMO
pathway, by involving a SUMO-targeted ubiquitin ligase, RNF4, to target mutant CFTR linked to SUMO-2/3
poly-chains. These findings identified the first nonnuclear pathway for SUMO modification and degradation of
an integral membrane protein. Protoarray analysis for SUMO binding proteins identified the SUMO E3 enzyme,
PIAS 4, which modifies CFTR with SUMO-1, a paralog that cannot form poly-chains, and therefore obviates
RNF4-mediated degradation. PIAS4 stabilizes the immature forms of WT, F508del and numerous rarer CFTR
misfolding variants, and it increased the efficacy of correctors of F508del CFTR trafficking to the plasma
membrane. With this Preliminary Data, the current proposal will evaluate the hypothesis that different SUMO
paralogs mediate CFTR biogenesis vs. degradation using different components of the SUMOylation pathway.
Aim 1 focuses on the mechanisms of PIAS4/SUMO-1 induced CFTR biogenesis. It asks whether and how
SUMO-1 modification stabilizes F508del, and it relies on purification of WT CFTR and its NBD subdomains, as
well as limited proteolysis to assess the mechanistic basis of PIAS4-induced stability. This aim examines the
mechanism of the SUMO paralog switch determines CFTR fate: biogenesis vs. degradation. Aim 2 explores
the generality of the ability of PIAS4/SUMO-1 to enhance corrector action for numerous rarer folding mutants,
which has allowed their partitioning into three classes of corrector response. Selected variants from these
groups will be examined to ask whether their behavior correlates with inherent differences in stability and
protease sensitivity. Aim 3 uses results from the SUMO Protoarray to identify HDAC6 as a mediator of non-
proteasomal degradation of specific mutants with the hypothesis that chaperone-mediated autophagy is
required for their disposal, and it will evaluate the ability of current small molecules to provide therapy of these
variants. It is critical that these studies of CFTR fate are performed in airway cells and wherever possible, in
differentiated primary cultures of human bronchial epithelia (HBE), whose phenotype has been predictive of
small molecule efficacy in clinical studies. This project will provide a mechanistic understanding of new quality
control pathways and define their impact on the conflict between protein folding and degradation.

Public health relevance
Narrative: This work examines the impact of SUMO modification on the biogenesis vs. degradation of the cystic fibrosis (CF) gene product, CFTR. Most CFTR mutations cause misfolding and premature degradation of the protein, preventing its trafficking to the apical membranes of epithelial cells. Understanding the ability of SUMO to increase CFTR biogenesis will enhance our knowledge of the CFTR folding pathway and support therapeutics development for CF.